Pathological AMPA receptor adaptations governing dependence-escalated alcohol self-administration

Project Summary
Alcohol dependence and multiple withdrawal experiences are related to increased severity of alcohol use
disorder (AUD), craving, and resistance to treatment. Alcohol abuse gains control over behavior, in part, through
pathological adaptations of glutamatergic AMPA receptor (AMPAR) mechanisms that regulate synaptic and
behavioral plasticity in brain reward pathways. The unique auxiliary protein, transmembrane AMPAR regulatory
protein (TARP) γ-8, has been shown to regulate AMPAR trafficking, activity, and CaMKII-dependent plasticity,
making it critical for AMPAR mediated neural transmission. An important feature of TARP γ-8 is its highly
restricted expression limited to corticolimbic regions known to regulate glutamatergic response to alcohol
including the medial prefrontal cortex (mPFC), basolateral amygdala (BLA), and the hippocampus, while
noticeably absent from the nucleus accumbens (NAc). Evidence indicates chronic alcohol increases glutamate
levels, which in turn promotes the influx of calcium, and initiating a cascade where CaMKII phosphorylates
AMPARs to increase and sustain AMPAR activity. Since AMPAR activity is required for the development of new
behavior (e.g., learning) and retention of actions (e.g., memory), this fundamental neural process may underlie
the development, maintenance, and critically, dependence-escalated self-administration of alcohol. Therefore,
this K99/R00 proposal will determine if TARP γ-8 regulates AMPAR mediated transmission in key brain regions
during dependence-escalated alcohol self-administration. Aim 1 (K99 phase) of the proposal will investigate the
role of TARP γ-8 dependent excitatory Ca2+ signaling in reward-related brain regions during alcohol self-
administration in the mPFC, BLA, NAc, and vHPC using a highly novel multi-spectral, four-channel fiber
photometry platform. Aim 2 (K99 phase) will examine TARP γ-8 as a mechanism of CIE vapor dependence-
induced escalation of alcohol self-administration and the consequential co-localization of TARP γ-8 and AMPAR
using confocal microscopy. Aim 3 (R00 phase) combines these techniques to evaluate Ca2+ signaling in key-
reward brain regions during dependence-escalated alcohol self-administration. These findings are then extended
by taking a circuit-based approach using a selective pharmacological manipulation in combination with fiber-
photometry to evaluate site-specific TARP γ-8 bound AMPAR inhibition on “bottom-up” (BLA to NAc) and “top-
down” (mPFC to NAc) Ca2+ signaling. This work moves the field forward by providing fundamental mechanistic
insights into TARP γ-8 dependence-escalated alcohol self-administration which has high translational value for
understanding and treating AUD and has the potential to inform development of new pharmacotherapeutic
strategies that target AMPAR function in a highly-selective brain region specific manner.

Public health relevance
PROJECT NARRATIVE Alcohol dependence and multiple withdrawal experiences are related to increased severity of alcohol use disorder, craving, and resistance to treatment. Studies proposed in this preclinical application take a multidisciplinary genetic, pharmacological, and molecular approach to elucidate the role of TARP γ-8, a novel AMPAR auxiliary protein, in the regulation of dependence-escalated alcohol self-administration.